ACTG 362 TRIAL TO DETERMINE EFFICACY OF AZITHROMYCIN PROPHYLAXIS

The purpose of this study is to determine whether once weekly azithromycin prevents Mycobacterium avium Complex (MAC disease) in people who have at one time had a CD4 count less than 50 cells but who now have a CD4 count above 100 cells.